Hypertension-associated Trained Immunity in Myeloid Cells is a Determinant of Atherosclerosis

PROJECT SUMMARY
Hypertension is a leading modifiable risk factor for global mortality and a key driver of atherosclerotic
cardiovascular disease (CVD). Despite aggressive lowering of cholesterol and blood pressure, up to 50% of
patients still suffer recurrent cardiac events. While this “residual risk” is likely due to chronic inflammation, what
drives inflammation once hypercholesterolemic and hypertensive stimuli have been resolved is poorly
understood. Recently, a phenomenon known as trained immunity—in which innate immune cells form long-
lasting memory—has been described. In training, an initial stimulus rewires the epigenome (i.e. enhancers) of
myeloid precursors thereby maintaining them in a primed state so that their mature progeny mount an augmented
response to a wide range of subsequent stimuli. We propose the novel concept that hypertension results in
trained immunity that predisposes to inflammation and atherosclerosis independent of blood pressure. We have
new preliminary data in support of this concept: 1) transplant of hematopoietic stem and progenitor cells (HSPCs)
from angiotensin (Ang) II-induced hypertensive mice into irradiated Western Diet-fed low-density lipoprotein
receptor deficient (Ldlr-/-) mice accelerates atherosclerosis, as compared to HSPCs from normotensive mice; 2)
cellular metabolism and epigenome organization in monocytes differentiated from these HSPCs remain altered
months after exposure to Ang II; 3) in vitro Ang II-trained myeloid cells have an augmented pro-inflammatory
cytokine response and increased signaling downstream of Dectin-1 — a non-canonical receptor for Ang II
implicated in other forms of trained immunity; 4) blocking Dectin-1, but not the canonical Ang II type 1 receptor
(AT1R) prevents the Ang II-training phenotype in vitro; 5) polymorphisms in the gene for Dectin-1 associate with
atherosclerotic and inflammatory vascular diseases in a human phenome-wide association study. Thus, we
hypothesize that hypertension induces trained immunity by epigenetically rewiring immune progenitors via a
Dectin-1 pathway, contributing to chronic unresolved inflammation and the long-term increased risk of
atherosclerotic CVD associated with hypertension. We will address this hypothesis through the following specific
aims: Aim 1. Determine how hypertension-induced training of myeloid progenitors rewires the mature monocyte
epigenome to promote a pro-atherogenic cell state and enhanced T cell activation. Aim 2. Determine whether
hypertension-induced trained immunity and augmented atherosclerosis are specific to Ang II. Aim 3. Establish
the mechanism by which Ang II promotes trained immunity in myeloid cells.

Public health relevance
PROJECT NARRATIVE There is an urgent unmet need to discover new therapies for patients with residual cardiovascular risk due to inflammation that is untreated by conventional cholesterol-lowering treatments. The goal of the proposed research is to uncover novel mechanisms by which we can address chronic inflammation in atherosclerosis. Therefore, this work is highly relevant to the mission of both the NIH and the NHLBI as it will help us understand fundamental mechanisms of disease in order to improve human health.